Leveraging immune-fibroblast interactions for biomaterial induced skin regeneration

PROJECT SUMMARY
Regeneration of native skin elements – hair follicles, sweat glands and adipose tissue, is a highly thought
after outcome of wound healing. While, in principle, very large skin wounds in adult mice can spontaneously
regenerate new hair follicles and new adipocytes, commonly studied small wounds in mice and clinical wounds
in humans heal with a far less desirable fibrotic scarring. If and how adult skin wounds can be directed to replace
the natural tendency for healing with a scar with regeneration of native skin elements remains unknown.
This application is inspired by a serendipitous discovery that adding an antigen to our novel biomaterial, the
Microporous Annealed Particle (MAP) hydrogel, can induce regeneration of new hair follicles when added into
normally fibrotic small mouse skin wounds. This immunomodulatory MAP gel provides wound-resident immune
cells with the molecular triggers that elicit an adaptive immune response to enhance macrophage responses.
Further, our studies on naturally regenerating very large skin wound model show that macrophage-fibroblast
interactions are essential for stimulating new hair follicle regeneration.
Through an integrated bioengineering, bioinformatic and experimental approach, this application will
focus on testing our new hypothesis that by engineering MAP gels to have specific immune triggers, interactions
between T-cells, macrophages, and fibroblasts in the wound can transform normally profibrotic healing response
into highly desirable regenerative response. The first aim of the proposed research is to mechanistically establish
the lymphocyte and macrophage subsets and the molecular signaling pathways required for MAP formulations
we have created to elicit hair follicle regeneration. This will be achieved using bioinformatic analyses of
transcriptomics, proteomic, and functional profiling at single-cell resolution. confirmed with in vivo loss of function/
transgenic mouse studies lacking key immune pathways or cells MAP gels. The second aim is to engineer new
types of immunomodulatory MAP gels designed to maximally induce T-cells and macrophage pro-regenerative
signals while minimizing pro-fibrotic signals using a high-throughput in vitro assay. The third aim is to determine
how MAP gel-induced immune signals enhance lineage plasticity of wound fibroblasts that is prerequisite for
new hair regeneration. This will be achieved via an advanced bioinformatic analysis on single-cell transcriptomic
data and functional gain- and loss-of-function studies on wound immune cells and fibroblasts.
The study premise is based on newly accepted-for-publication and extensive preliminary data. The proposed
studies are significant because they will establish new immune cell-driven mechanism for enhancing fibroblast
plasticity and activating embryonic-like regeneration of native skin elements in adult wounds. The proposed
studies are innovative because they will establish new types of immune-modulating biomaterials, and new
paradigm of biomaterial-triggered regenerative response in adult tissues. In the future, the results of this study
will drive the development of next-generation immune-modulating wound biomaterials for potential clinical use.

Public health relevance
PROJECT NARRATIVE While wound healing by regeneration is highly desirable, skin wounds in adult mice and humans most commonly repair by fibrotic scarring. We discovered that when wounds in mice are treated with immune-modulating biomaterials, they heal by regenerating new hair follicles. Here, we propose a series of bioengineering and animal studies to test the hypothesis that immune triggers within biomaterials can shift interactions between wound immune cells and fibroblasts from fibrotic toward a highly desirable regenerative response.